Evaluating Area-Based Socioeconomic Measures from American Community Survey data

The objective of the proposed study is to evaluate the use of the ACS data for ABSMs. Specifically, this research will evaluate and provide recommendations to the cancer registry community for research on ABSMs based on ACS data.